Elucidating the role of the Toxoplasma residual body in cytoskeleton turnover

PROJECT SUMMARY/ABSTRACT
Toxoplasma gondii has the remarkable ability to infect virtually any cell type of almost all warm-blooded
animals and is arguably the most successful parasite on earth, having infected an estimated one-third of
humans globally. While initial infection typically resolves without complication, the parasite is able to persist
for the life of its host, and can re-emerge in the immunocompromised and immunosuppressed to cause fatal
disease. Toxoplasma, like other apicomplexan parasites, has an unusual cell cycle in which daughter cells
are fully assembled within a mother before cytokinesis. Because of its unusual features and regulatory
checkpoints distinct from mammalian hosts, the parasite cell cycle is an ideal target for therapy
In the final steps of Toxoplasma division, the mother cell organelles and cytoskeleton are degraded to
make room for the daughter cells. Because the daughter cells must insert their own cytoskeleton, including
the host cell invasion machinery, into the plasma membrane, this is a critical point in parasite assembly.
Once divided, the daughter cells remain connected through a poorly understood organelle called the
residual body. While the residual body was first described over 60 years ago, little is know about it. We have
found that maternal cytoskeleton is actively stripped from the plasma membrane and delivered to the
residual body, where it is then degraded. We have identified a ubiquitin E3 ligase that localizes to the
residual body, and is essential to the turnover of maternal cytoskeleton. Moreover, we have shown that
mistargeting of the E3 outside of the residual body results in premature degradation of the daughter cells'
invasion machinery, blocking the infective cycle. We have therefore identified the sequestration of protein
turnover as a major cellular function for the residual body.
The goal of the proposed studies is to (i) understand the functional role of the residual body in
Toxoplasma cytokinesis and the turnover of maternal materials, and (ii) to delineate the components of the
ubiquitination cascade that targets the parasite cytoskeleton. We will determine what other organelles and
structures are delivered to the residual body for turnover and identify the proteins that sequester E3 ligase
activity and cytoskeleton degradation within the residual body. Furthermore, we will build the components
required for the creation of an innovative reconstitution of the E3 ligase activity that will enable future
studies towards generating a mechanistic model of maternal cytoskeleton turnover.

Public health relevance
PROJECT NARRATIVE Apicomplexan parasites are the causative agents of a number of important human diseases including malaria, cryptosporidiosis, and toxoplasmosis. These parasites divide through an unusual paradigm in which daughter cells are fully assembled inside the mother cell and remain coupled to one another through a poorly understood organelle called the residual body. Our goal is to use a recently identified ubiquitin ligase as a tool to understand how the Toxoplasma residual body sequesters turnover of essential complexes to prevent destruction of growing daughter cells.